MRI and X-ray catheter design and prototyping

During the past year we have continued our work developing magnetic resonance imaging (MRI) compatible and visible devices to perform endoluminal interventional procedures that are planned to perform under MRI.

We have been working to develop clinical-grade MRI catheter devices at 0.55T including
- Active MRI guidewire receiver coil
- Active MRI needle receiver coil
- Active MRI myocardial biopsy forceps

We have invented several first-in-class interventional devices for novel therapeutic non-surgical procedures. These include devices for trans-atrial catheter-based tricuspid valve repair, transcaval access to the aorta to enable transcatheter aortic valve replacement in patients with no good options, non-surgical access to the left atrium, novel vascular introducer sheaths, and extra-anatomic bypass for congenital heart disease without surgery. Many of these include inventions and patent applications for novel medical devices, such as purpose-built closure devices for transcaval access to the aorta, novel intramural implants to treat cardiomyopathy, and novel catheter tools for structural heart interventions.

We also work with industry to translate our laboratory inventions into the private sector for patient care. We have entered into collaborative research and development agreements with a large catheter company, research agreements with small catheter company to co-develop some devices. We also have sponsored Small Business Innovation Research contracts from our intramural laboratory to shepherd novel high-risk technology through small businesses into clinical testing.